Defining tumor and blood-based immunogenomic signatures predicting response to immunotherapy in ovarian cancer

The advent of immunotherapies (IO) such as immune checkpoint inhibitors
(ICI) heralded a significant improvement in cancer patient survival, but the mechanisms underlying treatment
response are still opaque. The level of tumor-infiltrating lymphocytes (TILs) has been suggested as one potential
ICI response biomarker, signaling an active anti-tumor immune response. So-called hot tumors, those with
many TILs, are more frequent in some cancers (e.g. melanoma) than others (e.g. ovarian cancer, OC). Strategies
to recruit additional TILs and thereby make cold tumors hot are in development, including the use of oncolytic
viruses (OVs). Refining IO outcome predictors, for both ICI and OV therapies, is an unmet clinical need.
Expanding on my previous findings of a novel germline genomic biomarker of ICI resistance in the circulating
CD8+ T cells of metastatic melanoma patients (H-MAX), I hypothesize that inherited immune biomarkers can be
identified in other IO-treated cancers. Whether such markers are the same for hot tumors like melanoma, or
differ for cold tumors such as OC, remains to be seen, as does their applicability to novel IO combinations such
as those including OVs. Understanding the interplay between circulating and tumor-infiltrating immune cells and
charting the dynamic post-treatment changes in the immune landscape may further illuminate the anti-tumor
responses induced by IO therapies. This proposal aims to answer these questions using peripheral blood and
tumor samples from IO clinical trials of ICI alone (NRG-GY003; NCT02498600) or in combination with OV
(ONCOS-102; NCT02963831). Sequencing these samples, I will define the inherited and acquired mutational
profiles of these patients (Aim 1.1), correlating these with their treatment outcomes. I will then assess their
association with known (e.g. TILs) and novel (e.g. H-MAX) IO biomarkers in both OC and other cancers. Using
high-resolution spatial profiling, I will then map the pre-treatment (NRG-GY003) and pre- and post-treatment
(ONCOS-102) tumor immune landscape (Aim 1.2), correlating these profiles with IO response and the genomic
signatures in Aim 1.1. Sequencing both tumor and peripheral blood TCRs from NRG-GY003, I will identify the
baseline tumor-resident TCR sequences and, using post-treatment blood samples, map their expansion in the
periphery following ICI treatment (Aim 2). I will conduct the same analysis in ONCOS-102, for which I also have
post-treatment tumor samples, allowing me to correlate the changes in circulating TCR profiles with those in the
tumor. I will also use ECCITE-seq, an emerging technology for obtaining single-cell proteomic, transcriptomic,
and TCR data, to profile pre/post-treatment ONCOS-102 peripheral blood mononuclear cells. With this deep
profiling, I will precisely define the cellular phenotypes and TCR repertoires of the reactive T-cell clones, charting
their dynamic post-treatment evolution following combined OV and ICI treatment. Collectively, the results from
this work may identify novel OC response biomarkers, potentially improving treatment stratification and pointing
to mechanisms of IO response and resistance.

Public health relevance
While immunotherapy treatments have significantly improved cancer survival, not all patients benefit, and reliable outcome biomarkers are limited. With this proposal, I aim to understand why some patients respond better to these treatments than others, and whether this can be predicted by genetic and phenotypic markers in tumor and immune cells. Ultimately, the goal of this work is to define personalized immunotherapy treatment biomarkers to improve patient response and survival.